Investigating the protective role of nicotine in treating chemotherapy-induced peripheral neuropathy

Project Summary/Abstract: Chemotherapy-induced peripheral neuropathy (CIPN), a consequence of peripheral nerve fiber dysfunction or degeneration, continues to be a dose-limiting and debilitating side effect during and/or after cancer chemotherapy. Potential interventions are needed due to the current lack of effective preventative or therapeutic treatments. The nicotinic acetylcholine receptor (nAChR) agonist, nicotine, is capable of preventing the development of mechanical allodynia induced by paclitaxel, a taxane commonly used to treat breast, lung, and ovarian cancers, in a mouse model of CIPN. Previous studies suggest that CIPN, specifically induced by paclitaxel, may be a result of inflammatory processes. The literature also demonstrates that nicotine can protect neurons from various sources of toxicity via activation of the α7 nAChR subtype. Therefore, the aims of this work are to determine if nicotine is neuroprotective in a mouse model of paclitaxel-induced peripheral neuropathy via the α7 nAChR. Wild-type and α7 nAChR knockout mice will be treated with paclitaxel and/or nicotine followed by an assessment of mechanical allodynia with the von Frey test and of intra-epidermal nerve fiber (IENF) loss with confocal microscopy. Subsequently, the site of nicotine-mediated α7 nAChR activation will be investigated with Cre/lox macrophage-specific knockout of the α7 nAChR. These mice will also be treated with paclitaxel and/or nicotine, then tested for mechanical allodynia and analyzed for pro-inflammatory cytokines via an ELISA in various sensory tissues, including the hind paw epidermis, dorsal root ganglia, and spinal cord. After identifying the involvement of the α7 nAChR in the protective role of nicotine, the pro-inflammatory effects of paclitaxel and potential anti-inflammatory role of nicotine will be further investigated by evaluating macrophage infiltration/microglial activation via immunohistochemistry. Lastly, nicotine will be chronically administered alone and in combination with paclitaxel in non-small cell lung cancer tumor-bearing mice in order to ensure that nicotine will not stimulate tumor growth or interfere with the anti-tumor effects of paclitaxel in vivo. Findings of the proposed work can be utilized to develop selective agonists and allosteric modulators for the α7 nAChR to further improve efficacy and minimize any potential side effects or remaining concerns regarding nicotine. Most importantly, it is possible that this site of therapeutic intervention is common to some or all neuropathy-inducing chemotherapy drug classes, including vincristine, platinum compounds, and bortezomib.

Public health relevance
Project Narrative: Chemotherapy-induced peripheral neuropathy (CIPN) is a result of peripheral nerve fiber dysfunction or degeneration that occurs in the majority of cancer patients treated with chemotherapy. There is currently no preventative treatment for CIPN, and the therapeutics available perform modestly at best in alleviating CIPN-induced neuropathic pain. A better understanding of the mechanism(s) of CIPN and how to target the pathway(s) involved will allow for the development of efficacious, preventative treatments, which will ultimately improve the quality of life of cancer patients and allow for the use of the most promising cancer chemotherapy regimen to prolong survival.